Social media support groups for adolescent vaping cessation

ABSTRACT
Tobacco use causes one third of cancer-related mortality. Decades of tobacco control progress are threatened
by the promotion and popularity of e-cigarettes (colloquially called “vaping”) by adolescents. Almost a decade
ago, e-cigarettes became the most common tobacco product used by adolescents. In 2022, 2.55 million U.S.
middle and high school students currently used e-cigarettes. Recently new “pod vape” devices have increased
in popularity; they are highly discreet and deliver high levels of nicotine increasing addictive potential.
Adolescent vaping is associated cigarette smoking initiation, and e-cigarette use increases risk of asthma,
adverse cardiovascular effects, and is likely to increase risk of lung cancer. To address this problem, flexible,
scalable evidence-based interventions are needed to help adolescents quit.
However, there are few adolescent interventions for e-cigarette use with rigorous evaluation data. To the best
of our knowledge, no vaping cessation programs are delivered on social media. In 2022, 62% of adolescents
used Instagram, and 50% of adolescents used it at least once a day. We developed the program, “Quit the Hit”
that takes place in direct message groups on Instagram to support cessation among mid to late-stage
adolescents aged 13-21. The program was co-created with hundreds of adolescents and has been evaluated
in a randomized controlled trial. Preliminary data show significantly higher end of program abstinence rate in
the intervention arm than in the control (52% vs. 35%). Quit the Hit is promoted using social media advertising
and it is administered by expert facilitators. To expand the reach and assess the effectiveness of the Quit
the Hit, we propose to develop and evaluate a scalable version, the Quit the Hit Toolkit (QTHT) that can be
implemented by school districts, community organizations, and other groups. We propose three Aims.
Aim 1. Adapt the Quit the Hit Toolkit (QTHT) for implementation by youth serving organizations, assessing
organizational needs and capacities to implement the program, training materials and supports for providers,
and resources and guides for promotion and adoption. Aim 2. Evaluate the effectiveness of the QTHT
implemented with community partner organizations in a parallel-arm randomized controlled trial. Aim 3.
Document and Assess the implementation of the QTHT including treatment fidelity and adaptations,
organizational capacity, facilitators/barriers to implementation, and types of technical assistance needed to
sustain the intervention. We will evaluate the implementation using the RE-AIM framework.
We will use a Type 1 Hybrid Effectiveness/Implementation Design that speeds translation from research to
practice by enabling us to test the intervention’s effectiveness while also gathering information on its potential
for large scale implementation in diverse settings. We have established partnerships with state health
departments, the California State Board of Education, and the Stanford Tobacco Prevention Toolkit which has
reached over 2.7 million youth for future dissemination.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) As much as 50-60% of cancer is preventable, and tobacco is by far the leading preventable cause of cancer, accounting for one-third of cancer mortality. Interventions to stop adolescent e-cigarette use “vaping” are important for cancer prevention, as those who vape are almost 4 times more likely to smoke cigarettes. Lessons learned from developing effective social media interventions for adolescents can also be applied to enhance other cancer-related communication efforts to improve equity in cancer control and treatment.